Arkansas Center for Health Disparities T32 Pre-doctoral Research Training Program

PROJECT SUMMARY/ABSTRACT
This proposal seeks to create a pre-doctoral training program “Arkansas Center for Health Disparities T32
Pre-doctoral Research Training Program” (ARCHD-T32) in the Department of Health Policy and Management
at the University of Arkansas for Medical Sciences (UAMS). The program builds on the research infrastructure
of the National Institute on Minority Health and Health Disparities (NIMHD) funded Arkansas Center for Health
Disparities (ARCHD) Center of Excellence and five social science PhD programs across the College of Public
Health, the College of Pharmacy, and the College of Nursing with support from the Department of Biomedical
Informatics in the College of Medicine. ARCHD-T32 provides a formal structure for integrating advanced
analytics into social science programs through didactic and applied settings with a focus on reducing health
disparities and improving health equity consistent with the priorities of NIMHD. ARCHD-T32 participants will
benefit from the ARCHD COE as it provides funding for two research projects, pilot funds for new investigators,
and community-engaged research infrastructure. ARCHD-T32 leverages the unique data assets of the UAMS
data warehouse, external partners, and the Arkansas All Payer Claims Database to address three specific
aims: 1) Create a formal structure for training social scientists in disparities/health equity research using
advanced data analytics and a team science approach; 2) Develop formal externship programs with key
partners in the state; and 3) Collaborate with the ARCHD, the Translational Research Institute, Regional
Programs, the newly formed Institute for Digital Health and Innovation at UAMS and the Institute for Advanced
Data Analytics at the University of Arkansas, as well as other national programs. A formal organizational
structure including a Multiple Program Director plan that combines expertise from the social sciences,
analytics, biostatistics, and informatics is proposed to meet five primary objectives: to recruit a diverse group of
trainees with quantitative backgrounds/capabilities and an interest in disparities research; to develop a high-
quality, individualized training program in advanced analytics directed at identifying and eliminating healthcare
disparities; to increase the workforce in Arkansas and the nation that has advanced analytics capabilities and
can contribute to identifying and eliminating healthcare disparities; to foster a training environment based on
interdisciplinary expertise and team science that responds to community needs; to evaluate the breadth of the
training program with respect to the overarching goal of creating a diverse training program that meets the
needs of the state and the nation. Support is requested to create four cohorts of two predoctoral students with
two-year training commitments. With technical and financial resources from UAMS and state partners, the
proposed training program serves as a national model for addressing health equity using advanced analytics in
an environment with pronounced health disparities.

Public health relevance
PROJECT NARRATIVE Researchers in the social sciences lack formal training in advanced analytics that may slow progress in understanding complex relationships between social determinants of health and population health outcomes. Multi-disciplinary, team-based science can align research methods in advanced analytics with social science perspectives to produce a new generation of researchers addressing racial and ethnic disparities in healthcare to improve health equity. As the only NIMHD T32 research training program in the state, the proposed program will serve as model to improve disparate population health outcomes in the state, region, and nation.